DP21-001 SC Pregnancy Risk Assessment Monitoring System (SC PRAMS)

SOUTH CAROLINA (SC) PRAMS PROJECT SUMMARY/ABSTRACT
The SC PRAMS program will collect data from mothers that have recently delivered live-born
infants about their behaviors, experiences, and attitudes before, during, and after pregnancy. The
broad, long-term objectives of this project are to improve the overall health and outcomes for SC
mothers and infants.
More specifically, data collected by SC PRAMS will be used to monitor progress toward the
Healthy People (HP) 2020 Maternal and Child Health (MCH) objectives, identify cost-efficient
ways to reduce maternal and infant morbidity and mortality, and inform and evaluate the SC
Department of Health and Environmental Control (DHEC) MCH programs. Improving the health
status of pregnant women, newborn infants, and post-partum women are important components
of the DHEC mission, which is to improve the quality of life for all South Carolinians by
protecting and promoting the health of the public and the environment.
SC PRAMS data collection will be conducted by taking a stratified, systematic monthly sample
of SC mothers with a live birth, who will then be surveyed about their behaviors, experiences,
and attitudes before, during, and shortly after pregnancy. Data collection will be primarily done
by mailed surveys, with a telephone follow-up phase for mail non-respondents. A combined mail
and telephone response rate of 55%, which is set by the Centers for Disease Control and
Prevention (CDC), will be a primary data quality goal.
Data collected will be weighted by the CDC to be representative of the population of SC women
delivering live births in the state annually. Collected data will be analyzed by qualified staff
within DHEC to assess maternal and infant health trends, characteristics of mothers and infants
with selected morbidities, and the performance of programs. Data collected will also be available
to CDC staff as well as to university, government, and private researchers across the United
States (US).
For the upcoming project period, the SC PRAMS program looks to improve response rates in
coordination with our contractor, improve messaging and outreach, and improve collaborations
within SC so that SC PRAMS data and information can truly inform programs and policies in SC
related to maternal and infant health.

Public health relevance
SOUTH CAROLINA (SC) PRAMS PROGRAM NARRATIVE The data collected and analyzed as part of the SC PRAMS program will be used to assess the overall health of mothers and infants in SC, and to inform and evaluate programs charged with improving the health of this population. The health of mothers and infants is a key component of overall public health.